Admin. Core

Administrative Core The overall goal of the Administrative Core is to provide high-quality support to the Arkansas INBRE network through shared governance that operates transparently and fairly. The Administrative Core will facilitate statewide communication and collaboration and will provide logistical support for the all the components of the network and the External Advisory Committee. With input from the Steering Committee and External Advisory Committee, the Administrative Core will oversee all research activities and training programs that meet the needs of faculty and students involved in biomedical research at partner and affiliate institutions. The Administrative Core will continue to support programs that increase undergraduate participation in research and expand participation of underrepresented minorities in the Arkansas INBRE network. Finally, the Administrative Core will represent the Arkansas INBRE in the national and regional networks of IDeA programs and will participate in efforts across these networks to share resources and best practices.

Public health relevance
PROJECT NARRATIVE FOR THE ADMIN CORE The Arkansas INBRE is a complex organization focused on expanding the biomedical research capacity within the State. Through strong leadership, the Administrative Core will continue oversight practices that lead to network sustainability and efficient utilization of resources. The Administrative Core will ensure that the Arkansas INBRE continues its history of strong productivity that is measurable in terms of impact through publications, success of its investigators in obtaining extramural research support, expansion of biomedical research infrastructure, and development of the next generation of biomedical researchers.